Development of Small Antimicrobial Peptide Mimics as Drug-Resistant and Susceptib

DESCRIPTION (provided by applicant): Malaria is a global disease causing > 500 million clinical cases and > 1 million deaths each year. Moreover, drug resistant Plasmodium falciparum has become a major problem. Therefore, it is crucial to discover new classes of drugs for anti-malarial drug design to combat resistant parasites. We propose that antimicrobial peptides (AMPs) may provide the basis of a novel class of antimalarials. AMPs are an essential component of the innate immune system. AMPs display very broad- spectrum action against bacteria, yeast, fungus by specifically disrupting their membranes rather than targeting proteins. Antiparasitic activities are also reported for a number of AMPs and are thought to kill protozoa by a mechanism similar to their mechanism of action against bacteria: interacting with plasma membranes, causing excessive permeability, lysis and death. Specificity for the parasite versus host cell is attributed to differences in phospholipid content and the lack of cholesterol in the protozoan membranes. Importantly, the site of action for AMPs is the plasma membrane and not any specific receptors or intracellular protein targets that can easily mutate to escape drug inhibition. Thus, the development of resistance to AMPs is less likely to occur. However, while AMPs have good antimicrobial activity, problems with tissue distribution and toxicity have presented obstacles to translating this expensive class of peptides into drugs. PolyMedix has developed series of small non-peptidic mimics of these AMPs (SMAMPs), which have robust, broad- spectrum activity against bacteria and markedly lower toxicity in animals. We propose SMAMPs may provide the basis of a novel class of antimalarials against which resistance will be intrinsically difficult to develop. SMAMPs from PolyMedix were tested and several kill Pl. falciparum parasites in culture having submicromolar IC50s and low cytotoxicity. Importantly, the top hits are active against both chloroquine-sensitive and resistant parasite lines. Our hypothesis is that they act through the perturbation of the food vacuole and possibly other parasitic membranes resulting in the rapid lysis of the food vacuole and parasite death. Membrane targets in bacteria for antimicrobials have been associated with a lower likelihood for developing resistance and this will be tested in Pl. falciparum. The goal of this grant is to validate and pursue antimalarial SMAMPs for therapeutic development. The Phase I portion generates proof-of-concept for this class of compounds through in vitro and in vivo efficacy testing. The Phase II segment aims to result in a discovery lead therapeutic candidate(s). Targeting parasite membranes using SMAMPs represents a highly innovative and novel approach to treating parasitic diseases and distinguishes this project from others in the field. Malaria is a global disease causing at least 500 million clinical cases and more than 1 million deaths each year. Moreover, drug resistant Plasmodium falciparum has become a major problem. Therefore, it is paramount to discover new classes of drugs for anti- malarial drug design to combat resistant parasites. We propose to develop novel antimalarial therapeutics using small non-peptidic mimics of naturally-occurring antimicrobial peptides. These therapeutics should prove to be potent, active against resistant parasites and display a low incidence of resistance.

Public health relevance
Project Narrative Malaria is a global disease causing at least 500 million clinical cases and more than 1 million deaths each year. Moreover, drug resistant Plasmodium falciparum has become a major problem. Therefore, it is paramount to discover new classes of drugs for anti- malarial drug design to combat resistant parasites. We propose to develop novel antimalarial therapeutics using small non-peptidic mimics of naturally-occurring antimicrobial peptides. These therapeutics should prove to be potent, active against resistant parasites and display a low incidence of resistance. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Malaria is a global disease causing at least 500 million clinical cases and more than 1 million deaths each year (1). Moreover, drug resistant Plasmodium falciparum has become a major problem. Therefore, it is paramount to discover new classes of drugs for anti-malarial drug design to combat resistant parasites. The class B biodefense agents Toxoplasma and Cryptosporidium, related members of the same phylum, also pose serious problems in immunocompromised individuals, and in veterinary infection (2). We propose that antimicrobial peptides may provide the basis of a novel class of antimalarials. Antimicrobial peptides (AMPs) are an essential component of the innate immune system that provides resistance to a variety of pathogenic bacteria and have provided new leads for developing antibiotics (3). AMPs display very broad-spectrum action against bacteria, yeast, fungus by specifically disrupting their membranes rather than targeting any proteins. Antiparasitic activities have also been reported for a number of host defense peptides and are thought to kill protozoa by a mechanism which is similar to their mechanism of action against bacteria-- by interacting with the plasma membrane, causing excessive permeability, lysis and death (4, 5). Specificity for the parasite versus the host cell is attributed to differences in phospholipid content and the lack of cholesterol in the protozoan membrane. Importantly, the site of action for antimicrobial peptides is the plasma membrane and not to any specific receptors or intracellular protein targets that can easily mutate to escape drug inhibition. Thus, the development of resistance to antimicrobial peptides is less likely to occur. However, while AMPs have good antimicrobial activity, problems with tissue distribution and toxicity have presented obstacles to translating this expensive class of peptides into pharmaceuticals. PolyMedix has developed a series of small non-peptidic mimics of these AMPs (SMAMPs), which have robust, broad-spectrum activity against bacteria and markedly lower toxicity in animals. One SMAMP is now in phase IB human clinical trials as an antibiotic to treat Staphylococcal infections. We propose that SMAMPs may provide the basis of a novel class of antimalarials that are intrinsically difficult to develop resistance against. SMAMPs from PolyMedix have been tested in the Greenbaum laboratory and several have been found to kill P. falciparum parasites in culture having submicromolar IC50s and low cytotoxicity. Importantly, the top hits are active against both chloroquine-sensitive and resistant parasite lines. Our hypothesis is that they act through the perturbation of the food vacuole and possibly other parasitic membranes resulting in the rapid lysis of the food vacuole and parasite death. Membrane targets in bacteria for antimicrobials have been associated with a lower likelihood for the development of resistance and this property will be tested in P. falciparum. The proposed goal of this Fast-Track grant is to mount a collaborative effort to validate and pursue antimalarial SMAMPs that are suitable for therapeutic development. The Phase I portion is to generate proof-of-concept for this class of compounds through in vitro and vivo efficacy testing. The Phase II segment aims to result in a discovery lead therapeutic candidate. During the course of this proposal, priority will be given to orally-bioavailable compounds. However, if orally-active compounds are not identified, parenterally-active compounds will be developed and chemical/formulation optimization will continue to achieve oral bioavailability. Targeting parasite membranes rather than proteins using SMAMPs represents a highly innovative and novel approach for treating parasitic diseases and distinguishes this project from most others in this field. Phase I Segment: Aim 1: Screening and design of potent, specific antimalarial SMAMPs. Highly active SMAMPs have been identified that suggest a new approach for the design of drugs against resistant P. falciparum. Thus, it is essential to screen the remaining compounds in the current library and prepare a new set of analogues to determine the molecular features required for optimizing antiparasitic activity. The outcome of these results will be a well-defined structure- activity relationship (QSAR) between the molecular features of the SMAMPs. This SAR will allow for the rational optimization of activity. Deliverable: Identify compounds active against multidrug resistant and susceptible parasites with an IC50<1 μM and in vitro efficacy/safety (selectivity) ratios greater than 100/1. Aim 2: Determine the mechanism of action for lead antimalarial SMAMPs. The Greenbaum lab has hypothesized that SMAMPs act on the membrane of P. falciparum and found that compounds acting by this mechanism should disrupt either the food vacuole as indicated by preliminary data and/or the plasma membrane. The Greenbaum lab will test the mechanism of action of the lead antimalarial SMAMPs. The initial focus will be on membranes but if it appears the membrane is not the primary target, we will investigate intracellular targets. Deliverable: The in vitro mechanism of action of the compounds will be determined in P.falciparum. Aim 3: Evaluate resistance development. The Greenbaum lab will measure the development of resistance in the lead antimalarial SMAMPS. Chloroquine sensitive 3D7 as well as choloroquine resistant Dd2 parasite lines will be subjected to increasing levels of lead SMAMPs over a period or 2-3 months to potentially select resistant parasites. Stability of resistance once compound is removed will also be tested. Deliverable: The ease of resistance development will be measured in vitro via serial exposure experiments. Parasites exhibiting at least 5 fold higher resistance to compounds will be used as a benchmark for potential resistance, and compounds that fail to generate resistance will be further analyzed. Aim 4: In vivo tolerability and efficacy in a mouse model of Plasmodium infection. Lead compounds will be tested in a rodent malaria parasite model measuring the extent of clearance in parasitemia and survival. Prior to efficacy testing, maximum tolerated dosages (MTDs) and pharmacokinetic properties for each of the selected compounds will be determined to help design dosing regimens. Deliverable: By the end of year two, establish proof of concept via in vivo efficacy model. The aim is to identify compounds that clear the parasite within 4 days of treatment without signs of relapse. Phase II Segment: Aim 5: Optimize SMAMP SAR for drug-resistant and susceptible malaria. The medicinal chemistry in Phase 1 will be focused on increasing the structural diversity of the lead series to improve anti-malarial activity and safety (in vitro selectivity), and define an SAR for the structural series under study. In Phase 2, synthetic chemistry will be focused on 1) refining the activity and selectivity of active compounds to improve in vivo efficacy and safety and 2) oral bioavailability. Deliverable: Identify compounds active against multidrug resistant and susceptible parasites with an IC50< 200 nM and in vitro efficacy/safety (selectivity) ratios greater than 500/1. Aim 6: In vivo efficacy and safety in the mouse model. Lead compounds identified in Aim 5 will be evaluated for 1) exposure levels following oral and parental administration and 2) tolerability in vivo in acute dosing studies. Compounds that are well-tolerated in mice and display predictable PK properties will be tested in the mouse efficacy model of Plasmodium infection. Priority will be given to orally-bioavailable compounds. Deliverable: identify a discovery lead molecule by the end of year 4 (year 2 of phase II) that is active against susceptible and resistant strains of P. falciparum, and active in an in vivo mouse model at dosages that elicit no adverse reactions. Aim 7: Lead compound scale up and process development. Lead compounds will be synthesized at multi-gram scales to supply required amounts for the animal efficacy and safety studies. Working from the original synthetic schemes, process chemistry will be developed to improve overall yields, reduce cost, and provide insights into the manufacturing feasibility of the particular lead compounds. Deliverable: synthesize sufficient quantities of compounds, of sufficient purity and yield, to allow for timely commencement of the activities in Aim 8. Aim 8: Pilot safety, stability and off-target activities. To prioritize compounds and help evaluate in vivo efficacy and safety results, assays will be done to measure the level of protein binding, stability in plasma and in the presence of liver hepatocytes, activity against receptors and enzymes with known pharmacological importance (including effects on CYP enzymes to identify potential drug-drug interaction liabilities), and mutagenic activity in a pilot Ames study. In addition, hERG testing and pilot toxicity in a pilot, non-GLP 7 day repeat dose rat study for approximation of a no-observed-adverse-effect-dose (NOAEL) will be conducted. Deliverable: By end of year 5 (year 3 of phase II), nominate a development lead compound with pharmaceutical properties suitable for clinical development.